Sitagliptin therapy to improve outcomes after islet autotransplantation.

DESCRIPTION (provided by applicant): Melena Bellin, MD is an Assistant Professor in the Department of Pediatrics, Division of Pediatric Endocrinology, at the University of Minnesota (UM). In this position, she devotes 75% of her time to patient-oriented research in the field of islet transplantation. Specific goals during this career development award period will include: 1) improved knowledge in clinical trials management, immunology, and islet transplantation; 2) publication of 2 peer-reviewed manuscripts per year; 3) completion of a clinical trial as described below; and 4) submission of a R-series research grant in the last 2 years of this award. Dr. Bellin has had formal training in patient-oriented research as a student in the M.S. program in Clinical Research at UM. She has been a co-investigator in cohort studies and small non-randomized clinical trials in islet transplant. She will build upon this foundation during the career development award period through formal training in more specific areas related to her research, attendance at national and international conferences in her field, and by conducting a large randomized clinical trial. Under the guidance of Dr. Antoinette Moran, the project mentor, Dr. Bellin will conduct a randomized double-blinded controlled trial evaluating the effect of sitagliptin treatment following total pancreatectomy and islet autotransplant on insulin independence and islet function. This project will have two aims: 1) to determine if treatment with a DPP-4 inhibitor after total pancreatectomy and islet autotransplant increases the proportion of recipients achieving insulin independence, and 2) to evaluate whether preoperative tests of islet function correlate with islet yield. Although incretin-based therapies have been used in very small, non-randomized trials of islet allotransplantation, this will be the first large randomized study to investigate such a therapy in islet autotransplant. Research projects will be conducted under the guidance of a mentor and co-mentors experienced in the fields of diabetes and islet transplant research-- Dr. Antoinette Moran, Dr. Bernhard Hering, and Dr. David Sutherland. The extensive experience with islet transplants at UM makes this an ideal environment for this research focus. Overall scholarly progress will be monitored by regular meetings with an advisory committee.

Public health relevance
PUBLIC HEALTH RELEVANCE: Islet transplant is an emerging new treatment for chronic pancreatitis and type 1 diabetes mellitus. This project will explore patient characteristics and an intervention which may improve the success of islet transplant. Project Narrative Islet transplant is an emerging new treatment for chronic pancreatitis and type 1 diabetes mellitus. This project will explore patient characteristics and an intervention which may improve the success of islet transplant. __SpecificAimsTextDelimiter__ 7.5.1 Research Plan 2. SPECIFIC AIMS There are an estimated 80,000 cases of pancreatitis a year in the US, resulting in 530,000 office visits, and costing $63.8 million (1). Chronic pancreatitis is often associated with incapacitating pain, narcotic dependence, and frequent hospitalization. Eventually, pancreatectomy may be considered to relieve pain. This leads to certain diabetes unless the islets are returned. Thus, in an autoislet transplant, a patient's own islets are recovered and given back following pancreatectomy for chronic pancreatitis. This is in contrast to alloislet transplantation, which involves delivery of cadaveric islets to individuals with type 1 diabetes (TID). When performed at specialized referral centers, islet autotransplantation can minimize diabetes burden in the majority of patients. The University of Minnesota is a major referral center for autoislet transplantation. This procedure is successful in about 2/3 of cases: approximately 1/3 of autoislet recipients are completely insulin-independent and an additional 1/3 require only a small amount of basal (background) insulin following the procedure. However, diabetes is not prevented in 1/3 of subjects, who require complete insulin replacement (2). The best indicator of transplant success is the number of islets that are harvested and available at the time of pancreatectomy (islet yield). Islet yield is compromised by the inflammation and fibrosis that accompany chronic pancreatitis, which result in variable and unpredictable degrees of islet stress, damage and destruction. Unfortunately, it is not currently possible to predict islet yield pre-operatively using clinical criteria. For example, it is not related to duration of pancreatitis, underlying diagnosis, gender, or narcotic requirements (2). There are no known pharmacologic interventions to increase the success of islet autotransplant. Interestingly, in small, non-randomized trials of islet allotransplant for T1D, administration of the GLP-1 analog exenatide results in reduction of insulin needs and increased proportion of patients achieving insulin independence (3,4). The DPP-4 inhibitor, sitagliptin, blocks the enzyme that degrades endogenous incretin hormones including GLP-1, thereby increasing endogenous GLP-1 levels. In murine models of islet transplant, sitagliptin treatment preserves transplanted islet mass, resulting in superior glycemic outcomes (5). For clinical use, sitagliptin has a practical advantage over exenatide in that gastrointestinal side effects are far fewer. This study will address two key questions. The first goal of this study is to evaluate whether treatment with once daily sitagliptin for 9 months following islet autotransplant increases the proportion of patients achieving insulin independence. The high volume of total pancreatectomy and islet autotransplant recipients at UM gives us a unique opportunity to address this question in a large, randomized placebo-controlled trial. This has clinical significance for both auto- and alloislet transplantation. Second, by performing metabolic testing immediately before surgery, this study will evaluate whether the results from simple metabolic tests can be used to estimate the islet yield at the time of surgery, as is suggested by our pilot data. The ability to estimate islet yield prior to surgery would contribute greatly to prognostic counseling about diabetes risk prior to surgery. SPECIFIC AIM #1 To determine whether treatment with sitagliptin after pancreatectomy and islet autotransplantation improves engraftment and islet function, and to determine if this effect is sustained. Ninety patients will be randomized in double-blind fashion to treatment with placebo alone (n=30) or treatment with sitagliptin (n=60). Treatment will be initiated on the day of pancreatectomy and continued for 9 months posttransplant. Mixed meal tolerance tests (MMTT) and intravenous glucose tolerance tests (IVGTT) will be performed before surgery and at 9 months and 18 months post- operatively. Insulin independence at 9 months is the primary endpoint of the study. Insulin independence at 18 months and insulin secretory response at 9 and 18 months are secondary endpoints. Hypothesis #1: The proportion of patients who are insulin independent or who are minimally insulin dependent (require <0.25 units/kg/day to maintain FPG <126 and 2h post-prandial glucose <180 mg/dl) at 9 months will be significantly greater in the group that receives sitagliptin. Hypothesis #2: Patients treated with sitagliptin will have better beta cell function as evidenced by insulin secretion in response to oral and intravenous stimuli at 9 months. Hypothesis #3: Because of the favorable effect of sitagliptin on islet engraftment and survival, the effects of sitagliptin on insulin independence and beta cell function will be sustained and remain clinically significant at 18 months post-transplant. SPECIFIC AIM #2: To determine whether pre-operative measures of insulin secretion predict islet yield in patients with chronic pancreatitis undergoing pancreatectomy and autoislet transplantation. Results from the preoperative MMTT and the IVGTT in all 90 patients will be used to determine the relationship of these measures with islet yield. Hypothesis #4: Acute insulin response (AIRglu) from the IVGTT will correlate positively with islet yield. Hypothesis #5: The IVGTT will correlate more strongly with islet yield than results of MMTT.